Research Project 2

SUMMARY/ABSTRACT – PROJECT 2
Project 2 of the Center on Causal Data Science for Child and Adolescent Maltreatment Prevention (CHAMP
Center) will involve proof-of-concept field testing of a decision support tool developed through collaboration
among Project 1, the Resource Core, and the Dissemination & Outreach Core. We will use the findings from
Project 2 to test our overarching hypothesis that predictive and causal data science can substantially increase
the scale at which maltreatment can be prevented and maltreatment-related outcomes can be mitigated.
Effective scalability of appropriate interventions remains a critical obstacle to efforts to reduce child abuse. No
matter the strength of the tools to support implementation or the extent to which the knowledge is shared,
implementation science cannot reduce the incidence of maltreatment if the intervention to be implemented
uniformly targets a small number of causes in all children and families who are at risk. It is thus essential to test
whether tools developed using predictive and causal data science are sufficiently effective and safe to warrant
their dissemination. In Project 2, we will test whether the personalized and precise approaches developed as
part of Project 1 can reduce children’s risk of maltreatment safely and practically. Insights from the conduct of
Project 2 will feed back to Project 1, the Resource Core, and the Dissemination & Outreach Core so that these
groups can learn from the results and iteratively improve on models and translational processes central to the
CHAMP Center. Evidence indicating problems in any of these areas will be considered by relevant members of
the cores, who will decide whether to conduct further discovery research or to refine the tools. Decision support
tools produced via collaboration among Project 1, the Resource Core, and the Dissemination & Outreach Core
will be tested in a clinical trial.